RNA Aptamers as Probes and Modulators of Coagulation

Project 3-Abstract
The overall objectives of this project are A.) to generate and employ RNA aptamers as probes to develop a more
thorough understanding of the specific macromolecular interactions that control blood coagulation and B.) to
utilize this new knowledge to generate potent, yet rapidly reversible, agents to regulate this process for research
and clinical applications. Using high resolution X-ray crystal structure data to guide us, we will rationally generate
and evaluate bifunctional EXosite-ACTive site (EXACT) inhibitors based upon aptamers and small molecule
active site inhibitors. We hypothesize that such bifunctional agents will be particularly potent inhibitors of
coagulation factor activity as blood feeding animals have employed this approach to create/evolve extremely
potent inhibitors, such as hirudin and tick anticoagulant peptide (TAP), in nature. For such bioinspired, X-ray
structure guided studies, we will covalently link an aptamer that specifically binds a specific clotting factor to an
active site proteinase inhibitor to achieve potent and specific inhibition of proteinase function. Moreover, we
hypothesize that an antidote oligonucleotide can made against the aptamer portion of the conjugate to rapidly
and fully reverse such potent EXACT inhibitors.
Our three specific aims are:
Aim 1: Conduct proof-of-concept studies with thrombin to optimize an approach for potent and bivalent
specific inhibition wherein specificity for the proteinase is provided by an aptamer and inhibition of
active site function of thrombin arises from a small molecule ligand coupled through a linker to the
aptamer. We have termed such bifunctional agents “EXACT” inhibitors as they target both an EXosite
and the ACTive site on the same proteinase.
Aim 2: Evaluate the generalizability of the studies on thrombin by producing and characterizing bivalent
EXACT inhibitors for factor Xa (FXa), factor XIa (FXIa), activated protein C (APC) as well as a
prothrombinase-specific inhibitor which does not inhibit free factor Xa.
Aim 3: Characterize EXACT anticoagulant function in ex-vivo models of ECMO (extracorporeal
membrane oxygenation) and in vivo models of ECMO and CPB (cardiopulmonary bypass) that lead to
fulminant activation of coagulation.

Public health relevance
Project Narrative Coagulation enzymes form macromolecular complexes to modulate important biological processes that are critical to normal health but become dysregulated in disease. One critical pathway that needs to be exquisitely controlled for human life is the coagulation system as to much blood coagulation leads to thrombosis, pathological blood clotting, and potentially death if it occurs in vital organs whereas to little coagulation can result in life threatening bleeding. In this proposal we will explore how such coagulation protein interactions tightly regulate this essential blood coagulation process using combinatorial chemistry and chemical biology approaches to generate novel probes for these processes. The results of these studies will yield a more thorough understanding of blood coagulation and potentially new therapeutic agents to limit thrombosis and bleeding in acute care settings.